Supplement for MINI point-of-use device

Abstract
We propose portable, proven, point of care/surveillance devices for use in SARS-CoV-2 testing that
expands upon the TINY (Tiny Isothermal Nucleic acid quantification sYstem) , which is called the
MINI. These devices leverage LAMP (loop mediated isothermal amplification) technology developed by
the Mason Lab in collaboration with technological developments from the Erickson lab to test up to 96
samples in real time. These devices can operate in areas without existing medical infrastructure with
portability and high throughput, filling an existing gap in the current SARS-CoV-2 testing infrastructure.
We also envision these devices as filling a necessary gap in COVID-19 surveillance, leveraging pilot
studies in detecting SARS-CoV-2 and other viruses in sewage to monitor the evolution of the pandemic
in the coming years and building an infrastructure to better monitor and predict future viral outbreaks.
A 96 well version of our existing TINY detection device, called the MINI, will be deployed at large scale to
develop surveillance and point of care testing for SARS-CoV-2 in wastewater, saliva, and other
samples. This technology is accompanied by an easy to use software package for exporting and
preserving results that can be installed on any computer. This technology is able to screen the most
prevalent circulating COVID-19 variants by targeting the viral envelope gene (E) and RNAse P (RP) gene.
These methods can help with the current COVID-19 outbreak and aid in future risk management and
pathogen mapping.

Public health relevance
Narrative We propose portable, proven, point of care/surveillance devices for use in SARS-CoV-2 testing that expands upon the TINY (Tiny Isothermal Nucleic acid quantification sYstem) , which is called the MINI. This device can process 96 samples at once using LAMP (loop mediated isothermal amplification) and enable tracking of viruses beyond SARS-CoV-2. These methods, devices, and tools will help in tracking COVID-19 and aid in future pathogen tracking.